The Long Life Family Study

The Long Life Family Study (LLFS) has enrolled 4,953 participants in 539 pedigrees in the USA and Denmark
that are enriched for exceptional longevity, and has measured them longitudinally in three extensive in-person
visits measuring key healthy aging phenotypes in all of the major domains of the aging process. We have
demonstrated through many publications that selecting on longevity in the first (proband) generation, results in
the second (offspring) generation being much healthier than average in many key phenotypes. Analysis of
Danish Medical Registry data suggested that the protection persists into this third generation. In Visit 3, we
expanded our LLFS pedigrees to include grandchildren. However, LLFS pedigrees are heterogeneous by
phenotype, with different families showing familial clustering of protection in cognition, grip strength, pulmonary
function, blood pressure, etc. Further linkage analysis identified extremely strong genetic linkage peaks for
cross-sectional as well as longitudinal trajectory rates of change phenotypes for a wide variety of healthy aging
domains such as exceptional cognitive performance and resilience to Alzheimer's Disease and Related
Dementias (ADRD). Pedigree specific LODs and Whole Genome Sequencing (WGS) suggests that these peaks
are driven by rare, protective variants running in selected pedigrees. Through linkage and genomc-wide analysis,
we found many new rare and protective variants for healthy aging phenotypes (HAPs), including a new gene for
AD, MTUS2. On a subset of the cohort (pedigrees with strong linkage evidence), we generated extensive
longitudinal OMICs (transcriptomics, methylomics and metablomics). Despite our success, LLFS is almost all
European Ancestry (EA). Adding African-Ancestry (AA) pedigrees will allow us to find new protective variants
that are unlikely to be found in EAs (because of genetic drift), and to better resolve the causal variants common
to both (because the haplotype blocks of AAs are only half as large as EAs reducing the “driver vs. passenger
problem”). Visit 1 was nearly 20 years ago. Since then, there have been many medical advances and healthcare
changes. We need to add a modest number of concurrent EA families, to contrast with the new AA ones, to
avoid the confounding of secular trends with ancestry differences. The offspring are now approaching 80 years
old on average, when expected disease incidence increases. Extending longitudinal follow-up of the original
pedigrees will better define HAP trajectories, giving greater power to find protective variants for EL and HAPs.
We will extend characterization of LLFS to additional domains microbiome, somatic mutation (CHIP), proteomics.
To examine associated haplotypes and structural variants, long-read sequencing is crucial. 70% of human
structural variation found in long-read WGS is missed by short-read WGS. Extending the omics to the full cohort
will help us understand mechanisms of action of associated variants to protective EL and HAPs. Finally, a more
sophisticated systems biology approach, including using state of the art Artificial Intelligence approaches, are
needed to fully understand the role of genes working in networks to produce HAPs and EL.

Public health relevance
As the rapid “graying of America” is fueling a future health care crisis, it is important to understand how some people are able to delay or escape aging-related disabilities and diseases, including Alzheimer’s Disease, and live much longer than average. We will expand the ethnic diversity of the unique Long Life Family Study of families exhibiting exceptional survival and healthy aging to discover the secrets of their protection. We will generate “Big Data” from their blood and DNA to discover the protective biological mechanisms, which could lead to new therapies and prevention approaches.